Glycolysis and Glutaminase in CD8 T cell differentiation and anti-tumor immunity

Summary
Immunotherapy has transformed cancer treatment and improved clinical outcomes, but it does not cure most
patients. Treatments such as anti-PD1 monoclonal antibodies and chimeric antigen receptor (CAR) T cells
function by boosting the activity of cancer-specific interferon gamma-producing Th1 CD4 T cells and
cytotoxic CD8 T cells (CTL). Increased effector function, however, must be balanced with the ability of anti-
cancer T cells to persist long-term. A key goal of immunotherapy is to enhance effector function while
maintaining T cell longevity and memory. It is now clear from work in the Rathmell lab that effector T cells
utilize high rates of glycolysis while memory cells utilize mitochondrial pathways. Here I propose to test cell
metabolism as a means to enhance both effector and memory T cell populations in immunotherapy. T cells
radically alter their metabolism upon activation and increase glycolysis and glutamine oxidation
(glutaminolysis) to support differentiation, effector function, and eventual generation of long-term memory that
depend on mitochondria. Modulation of T cell glutamine metabolism may augment the efficacy of
immunotherapy by enhancing both T cell effector function or memory capacity. The Rathmell Lab has shown
that the metabolic program aerobic glycolysis is essential for effector T cell (Teff) function in inflammation and
in tumors. Glutaminolysis complements glycolysis to fuel T cells by converting glutamine to the tricarboxylic
acid cycle intermediate alpha-ketoglutarate (aKG). Using a conditional knockout of the glutaminolysis enzyme
Glutaminase (GLS), which converts glutamine to glutamate, and an inhibitor of GLS that is currently in clinical
trials as an anti-cancer agent, we have found that inhibition of GLS leads to a compensatory increase in
glycolysis that enhances Th1 and CTL Teff function and differentiation. In addition to increasing effector
function, however, I found that GLS inhibition also increases expression of inhibitory receptors, and chronic
GLS deficiency ultimately suppresses T cells. In contrast, transient GLS inhibition enhanced Teff function while
also priming mitochondrial metabolism for a memory-like differentiation, and led to improved T cell persistence
in vivo. In this proposal, I will test the hypothesis that transient GLS inhibition can augment Teff function and
maintain T cell survival and memory to boost anti-cancer immunotherapy efficacy, whereas chronic GLS
inhibition will drive compensatory glycolysis, terminal Teff differentiation, and exhaustion. I will: (1) Test how
transient versus chronic GLS inhibition affects CTL fate by determining differences in memory T cell formation,
assessing the contribution of compensatory glycolysis to Teff phenotypes, and establishing the mitochondrial
consequences of GLS inhibition; and (2) Test the effect of GLS inhibition on the immunotherapy efficacy of
CD19-targeted CAR T cells and anti-PD1 treatment. These studies will demonstrate a new approach to
improve anti-cancer immunotherapy and highlight a strategy of using GLS inhibition to modulate T cell
metabolism and differentiation.

Public health relevance
Project Narrative T cells play a key role in anti-cancer immunotherapy responses, and it is important to develop new synergistic strategies to enhance effector T cell function and longevity. Modulating T cell metabolism is a novel approach to augment the efficacy of immunotherapy that can affect T cell differentiation. This study will demonstrate the effect of glutaminase inhibition on anti-cancer T cell fate to improve immunotherapy outcomes.